Metabolic mechanisms underlying bronchopulmonary dysplasia-associated pulmonary hypertension

SUMMARY
Bronchopulmonary dysplasia (BPD) is a chronic lung disease in premature infants, caused by mechanical
ventilation and hyperoxia amongst other factors. Thirty percent of infants with moderate to severe BPD develop
pulmonary hypertension (PH), characterized by pulmonary vascular remodeling. There are no curative therapies
for this disease. Current management is limited to relieving symptoms using pulmonary vasodilators, and
minimizing further lung vascular and alveolar insults. My long-term goal is to develop novel targeted therapies
to prevent and/or treat BPD associated pulmonary hypertension (BPD-PH). Pulmonary vascular remodeling is
characterized by increased smooth muscle cell-specific markers. This results from proliferation and migration of
vascular smooth muscle cells, or transdifferentiation from endothelial cells (ECs) to smooth muscle cells (i.e.,
endothelial-mesenchymal transition, EndoMT). We and others have shown that hyperoxia to newborn mice and
mechanical ventilation in preterm lambs cause pulmonary vascular remodeling resulting in PH. This is associated
with increased EndoMT, as shown in our recent publication and in preliminary data. We preliminarily show that
EndoMT is also observed in the lung of premature infants requiring mechanical ventilation, suggesting that this
may be causative in pulmonary vascular remodeling and PH. In mice, we have reported that neonatal hyperoxia
causes a persistent reduction of endothelial carnitine palmitoyltransferase 1a (Cpt1a), the rate-limiting enzyme of
the carnitine shuttle system responsible for transporting long-chain fatty acids into mitochondria for β-oxidation
during fatty acid oxidation. Our preliminary data show that lung Cpt1a gene expression is also reduced in
mechanically ventilated preterm lambs and premature human infants. Additionally, endothelial deletion of Cpt1a
increased EndoMT and pulmonary vascular remodeling in neonatal mice after exposure to hyperoxia.
Furthermore, pharmacological upregulation of Cpt1a attenuated hyperoxia-induced EndoMT in cultured lung
ECs. Whether neonatal hyperoxia and mechanical ventilation reduce endothelial Cpt1a, leading to PH is yet to
be determined. The central hypothesis is that neonatal hyperoxia and mechanical ventilation cause EndoMT by
downregulating endothelial Cpt1a, thereby resulting in pulmonary vascular remodeling and PH. We will test this
hypothesis in three Specific Aims. Aim 1 will determine the molecular mechanisms by which Cpt1a regulates
hyperoxia-induced EndoMT. In Aim 2, we will define the role of endothelial Cpt1a in neonatal hyperoxia-induced
PH and EndoMT. In Aim 3, we will evaluate endothelial Cpt1a and EndoMT as therapeutic targets for BPD-PH
using both lamb and mouse models. The combination of clinically relevant lamb and mouse models with our
newly generated EC-specific Cpt1a KO mice and newly developed nanoparticle delivery system provides an
innovative approach to uncover the mechanisms by which Cpt1a reduction mediates EndoMT and their
significant roles in BPD-PH. This contribution is significant because it is likely to result in new therapies
specifically targeting endothelial Cpt1a or EndoMT in neonates to prevent or cure BPD-PH.

Public health relevance
PROJECT NARRATIVE Supplemental oxygen and mechanical ventilation used in premature infants causes lung vascular remodeling and pulmonary hypertension. Our proposed studies will elucidate the metabolic mechanisms underlying endothelial-mesenchymal transition during the development of pulmonary hypertension using lamb and mouse models of bronchopulmonary dysplasia. This research will have significant translational potential for the development of novel pharmacological approaches targeting fatty acid metabolism or endothelial-mesenchymal transition to prevent pulmonary hypertension in patients with bronchopulmonary dysplasia.